Defining the Innate Immune Cell Profile of Factor VIII Immunity

PROJECT SUMMARY
The development of inhibitors (i.e., neutralizing antibodies) against infused coagulation protein factor VIII
(FVIII) is the most significant treatment-related complication in modern hemophilia A care. Administration of
frequent and high doses of FVIII over months-years, referred to as immune tolerance induction, remains the
primary strategy for inhibitor eradication for the last 40 years. There is a critical need for novel, innovative, and
less burdensome approaches to immune tolerance induction to restore FVIII hemostatic efficacy in the
management of acute bleeds or surgeries in persons with hemophilia A (PwHA) and inhibitors. Despite
numerous novel treatments recently approved or in the pipeline for hemophilia A treatment, the lack of
therapeutic strategies for inhibitor prevention or universally successful inhibitor eradication methods are
persistent barriers within the field that warrant continued research focus. Moreover, a poor understanding of
the underlying immunologic processes that mediate FVIII immunity further contribute to the limited
advancements in therapies for peripheral tolerance induction. The long-term goal of this work is to define the
key cellular components and early immunologic events that mediate FVIII immunity to ultimately develop and
test targeted immunomodulatory therapies that prevent inhibitor formation and induce peripheral FVIII
tolerance. The rationale for this R00 proposal stems from preliminary data demonstrating that type 2
conventional dendritic cells (cDC2) are key mediators in anti-FVIII antibody development in a murine model of
hemophilia A. Additionally, single cell RNA sequencing (scRNAseq) analysis show upregulation of phagocytic
and interferon genes by cDC2 following FVIII injections in hemophilia A mice signifying their contribution in
FVIII recognition and presentation. The central hypothesis is that with early FVIII exposure conventional DC
(cDC), specifically cDC2, mediate CD4+ T cell activation in a proinflammatory cytokine microenvironment that
induces B cell activation and production of inhibitory anti-FVIII antibodies. The central hypothesis will be tested
through the following 2 aims: 1) Define the cytokine microenvironment of cDC2 activation and CD4+ T cell
differentiation in FVIII inhibitor development, and 2) Determine the innate immune profile across the lifespan of
PwHA with and without inhibitors. Aim 1 will examine the cDC2-activated cytokine microenvironment, focusing
of interferon gamma (IFN-γ) and IL-12 production and cellular source, that dictates antibody production in FVIII
knockout mice with and without cDC2 depletion. Aim 2 will investigate and compare the innate immune
transcriptomic profile of peripheral blood mononuclear cells isolated from PwHA based on age groupings,
inhibitor status, and treatment regimen utilizing 10X Genomics scRNAseq and flow cytometry. This research is
significant because it will advance understanding of the innate immune response to FVIII and help illuminate
therapeutic strategies that can be administered during early FVIII exposure to prevent inhibitor development
and induce peripheral immune tolerance.

Public health relevance
PROJECT NARRATIVE The development of neutralizing antibodies, called inhibitors, against coagulation protein factor VIII remains a significant treatment-related complication that disproportionately affects children with hemophilia A impacting their quality of life. This proposal will investigate the innate immune profile, including the cytokine microenvironment, of inhibitor development using murine models of hemophilia A, patient samples, and novel transcriptomic tools. Ultimately, the work proposed will help elucidate mechanistic drivers of factor VIII immunity and foster increased investigative focus on alternative and innovative therapies for immune tolerance induction.